Sub-100 nm and scalable self-therapeutic nanoparticles to target autophagy in pancreatic cancer

Title: Sub-100 nm and scalable self-therapeutic nanoparticles to target autophagy in pancreatic cancer
Project Summary
The 5-year survival rate of pancreatic ductal adenocarcinoma (PDAC) is less than 10% and the lack of effective
treatment is one of the major impediments for the clinical management of PDAC. Pancreatic cancer stem-like
cells (PCSCs) have been linked to tumor metastasis, drug resistance, and aggressive behaviors and the
enrichment of PCSC after chemotherapy is associated with more aggressive tumor rebound. Autophagy is the
process of “self-digestion” and it is especially needed for the rapid proliferation in cancer cells. PDAC cells,
particularly PCSCs, highly rely on elevated autophagy. Therefore, autophagy is a promising target in PDAC to
improve treatment and overcome chemoresistance. Autophagy inhibition with aminoquinoline drugs, such as
chloroquine (CQ) or hydroxychloroquine (HCQ), have been tested in several clinical trials including PDAC
patients. Promisingly, an initial clinical benefit was observed when combined with chemotherapeutic drugs, such
as gemcitabine and Abraxane in neoadjuvant setting. However, CQ/HCQ have limited potency for autophagy
inhibition and potential side effects, and the concentrations of CQ/HCQ required to inhibit autophagy are not
consistently achievable in the clinic due to the lack of a specific delivery approach. The overall goal of this SBIR
phase I application is to develop sub-100 nm and scalable self-therapeutic nanoparticles as next-generation
autophagy inhibitors to improve PDAC treatment in preclinical animal models, providing validation regarding the
feasibility for Phase II studies that will eventually lead to an IND filing to FDA. Recently, we have developed an
Autophagy inhibitor Self-delivered Nanodrug (AiSN) that offers superior potency for autophagy inhibition and
specific drug delivery to improve PDAC treatment to HCQ. AiSN is a self-therapeutic nanoparticle that contains
pure bisaminoquinoline (BAQ) derivative itself as the building block which has outstanding autophagy inhibiting-
and lysosomal disrupting- capabilities. AiSN is 30x more effective than CQ and HCQ in vitro, and effectively kills
PCSCs. As a self-delivered nanoparticle without a carrier, AiSN can efficiently accumulate at the PDAC tumor
sites and effectively inhibit autophagy in PDAC animal models. AiSN successfully prevented tumorigenesis in
PCSC-derived animal models and demonstrated superior anti-cancer efficacy in both PDAC- and PCSC-derived
xenograft models as both a monotherapy and a combination therapy. These results were recently published in
Nature Communications and built a strong foundation for this Phase I application, in which we plan to 1) develop
a microfluidic approach for optimization of the AiSN formulation (smaller size, better stability and reproducibility)
to further enhance its tumor penetration and support future large scale-production, and 2) investigate the
pharmacokinetics, tumor penetration, and anti-cancer efficacy of the microfluidic assisted manufacturing AiSN
in animal models. The successful completion of the proposed research will make the AiSN ready for next step
of IND-enabling studies seeking IND approval. The proposed AiSN with greatly enhanced potency and specific
delivery properties will significantly improve the efficacy and minimize the toxicity in the treatment of PDAC.

Public health relevance
Project Narrative The significantly elevated autophagy in pancreatic cancer cells and pancreatic cancer stem cells leads to chemotherapy resistance, cancer recurrence, and metastasis, all of which are major challenges in the treatment of pancreatic ductal adenocarcinoma (PDAC). The proposed novel self-therapeutic nanoparticles could target PDAC tumor sites and effectively inhibit autophagy and lysosomal activities in both cancer cells and cancer stem cells, resulting in a remarkable therapeutic outcome without increased toxicity. This project is poised to significantly improve the clinical outcomes for pancreatic cancer patients by improving the response rate, prolonging the progression-free survival, and decreasing the long-term toxicity, therefore it has great commercial potentials to lead to a marketable nano-formulation to improve the treatment of PDAC.